The Contribution of Microglial MEF2C to Brain Development

Summary/Abstract
Intellectual disability and autism spectrum disorders are devastating disorders thought to arise from a combination of
synaptic dysfunction and altered neural progenitor modulation for which there are no effective treatments. Mutations or
deletions in one allele of myocyte enhancer factor 2C (MEF2C) result in MEF2C Haploinsufficiency Syndrome (MHS), a
disorder characterized by a severe phenotype with intellectual disability, repetitive motor behaviors, and difficulties with
communication and social interaction on the autism spectrum. We have found that MEF2C is highly expressed in human
microglia during neurodevelopment and have identified MEF2C as a core transcription factor involved in the microglial
cell fate. Furthermore, MEF2C expression is regulated by the brain environment and decreases during aging. Microglia
have not been extensively investigated in the pathogenesis of neurodevelopmental disorders, but there is increasing evidence
for their impact on brain development suggesting they may contribute to especially the social and behavioral deficits in
autism. The central hypothesis is that microglial MEF2C has a crucial role in human brain development and contributes
to neurodevelopmental disorders including intellectual disability and autism pathogenesis and the resulting behavioral
phenotype. We will utilize novel in vitro and in vivo methods to ascertain the role of microglial MEF2C in brain
development including synapse retention and pruning, modulation of the neural progenitor pool, and microglial
development. The project goal is to test the hypothesis that MEF2C specifically in human microglia contributes to brain
development and reduced expression contributes to neurodevelopmental deficits found in intellectual disability and autism.
Delineating MEF2C transcriptional and environmental targets using epigenetic techniques will yield novel insight into
human microglial transcriptional networks and expand on our knowledge of autism associated genes with the potential to
yield novel therapeutic targets. The long-term goal is to generate and validate methods using human microglia specifically
which can be utilized for drug screening and to generate preclinical data in order to ultimately identify novel potential
therapeutic targets to improve the outcomes for children with autism.

Public health relevance
Narrative The proposed research is relevant to public health because autism spectrum disorder (ASD) and intellectual disability are pervasive and debilitating disorders of childhood, with no targeted treatments. MEF2C Haploinsufficiency Syndrome (MHS) or 5q14.3 microdeletion syndrome are severe neurodevelopmental disorders with autism like features and destructive outcomes in affected children that result from loss of expression of the transcription factor MEF2C. This project is relevant to the NIH’s mission to enhance life and reduce disability, with a goal of understanding the role and regulation of intellectual disability and autism-linked genes like MEF2C in microglia and their resulting contribution to ASD pathology to identify novel potential therapeutic targets.